INHALATION EXPOSURE FACILITY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Inhalation Exposure Facility located at the CNPRC is one of the largest in existence on a university campus. It permits unique human health-related pulmonary research opportunities using nonhuman primates. Capabilities exist for in vivo or in vitro exposure to precisely characterized and controlled atmospheres of gases and aerosols. For health effects of air pollution research, the range of test subjects used for exposure studies can include animals, isolated and perfused lungs, tracheal explants and human or monkey lung cell cultures. This permits an integrated, comparative approach to defining mechanisms of respiratory system injury and repair. The pulmonary function laboratory offers a comprehensive array of testing for infant through adult nonhuman primates.Services Offered: + Special Exposures + Ozone Generation and Monitoring + Aerosol Generation and Analysis + NOx Generation and Monitoring + Allergen Generation and Analysis + Filtered Air Exposure + DCS Generation and Analysis Pulmonary Function Testing Laboratory + Baseline Airway Resistance Testing + Airway Responsiveness Testing + Allergen Responsiveness Testing + Static Lung Mechanics Testing + Late Phase Allergen Responsiveness Testing + Lung diffusing capacity, cardiac output and pulmonary capillary volume